Support for New Bioinformatics Methods Development

New bioinformatics method development support includes, image analysis for glyphosate toxicity where deep-learning based image processing tmethods were used to discriminate between normal, stressed and cell-death conditions of HepaRG cells and primary hepatocytes; Evidence tagging protocols were develop for evidence mapping for the OHAT group; an evaluation of existing tagging methods was performed currently available in the SWIFT-Review program; Machine Learning methods were used for Document tagging activity exploring alternative to the keyword-based tagging strategy currently used in SWIFT-Review.